CALORIC RESTRICTION AND AGING IN NONHUMAN PRIMATE EYES

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Dietary caloric restriction (CR) is the only intervention to reliably extend the lifespan of a variety of species, including worms, flies, fishes and rodents. Whether CR can also extend the human lifespan remains unknown. The National Institutes of Aging's Caloric Restriction Study maintains long-term colonies of nonhuman primates that are evaluated for many health parameters and markers of aging and provide the best available nonhuman primate model to address this question. As part of this unique resource, groups of rhesus monkeys, including young and old groups on 30% calorically restricted or ad libitum diets, were maintained at ONPRC for 4.5 years, and large groups are being followed throughout their lifespan at NIA. Because of its accessibility to noninvasive monitoring, the eye is an ideal organ to evaluate longitudinally whether CR can retard the occurrence of aging and age-related disease, and therefore we are conducting in-depth studies of ocular aging in these monkeys. The two major goals of our project are: 1) to determine whether CR retards the development of aging and age-related ocular diseases including macular degeneration, cataract, glaucoma and optic nerve atrophy;and 2) to correlate clinical observations with histopathological studies, using markers of age-related degeneration and oxidative stress. This research can provide new insights into the causes and possible treatment of human age-related ocular disorders. In the past year we continued evaluation of monkeys in the NIA CR colony, and completed morphological studies that contribute to understanding the cellular processes involved in age-related retinal disease.